Community Engagement Core & Science Communication

COMMUNITY ENGAGEMENT CORE - ABSTRACT
The overarching goal of the CEED Community Engagement Core (CEC) is to support the strategic vision of
CEED to address the environmental health concerns of all NJ residents by centering our efforts on its most
affected populations. CEC works with communities and CEED researchers to characterize the health risks that
people face in their daily lives, translate existing research evidence to action to reduce exposure and risks, and
identify new research directions that are aligned with community environmental health needs. CEC aims to 1)
Integrate community environmental health concerns with the overall CEED vision; 2) Improve environmental
health and reduce health disparities by building capacity in communities and within the Center to address
environmental health risks; and 3) Respond directly to community health needs and concerns by facilitating
community-engaged research (CEnR). To accomplish these aims, CEC establishes and nurtures active, long-
standing relationships with community partners who have common goals to improve environmental public health.
Through regular meetings and bidirectional communications, CEC facilitates sharing of diverse perspectives
between community partners and CEED scientists, increasing understanding of community concerns and ways
that environmental health science can address those concerns, reduce risk, and improve health. The CEC
Working Group meets monthly with CEC leadership and Community Advisory Board (CAB) members to plan
activities that include an annual NJ Environmental Health and Justice Summit. The CEC builds community
capacity to engage in research through an Environmental Health Ambassadors program and future scientist
programs, as well as CEnR projects addressing community concerns about traffic-related air pollution, local
impacts of climate change, and legacy and emerging drinking water contaminants. Communication and
engagement with community partners will be enhanced with more opportunities for in-depth dialog and co-
learning workshops. Training modules in environmental public health will facilitate the ability of CEED members
and community partners to participate in review of cumulative impacts assessments and permit decisions under
the state’s new environmental justice regulations. These sessions will build on Center strengths in geospatial
mapping, community air monitoring, and cumulative risk assessment. CEC will support increased participation
of community organizations in the Pilot Project Program by: 1) assisting community-scientist teams with project
development; and 2) preparing two CAB members to participate in the review of relevant pilot grant applications.
CEC will work with community partners to disseminate CEED science. Expanded initiatives in implementation
science will identify novel strategies to enhance translation of CEED science to evidence-based, multi-level
interventions that reduce exposures and health risks. Progress towards the CEC’s goal to translate CEED
science to action and impact will be evaluated by regular benchmarking and soliciting feedback from partners.